Unraveling myeloid-mediated mechanisms of immunotherapy resistance in prostate cancer bone metastases at single-cell resolution

PROJECT SUMMARY
Most patients with metastatic castration-resistant prostate cancer (mCRPC) are resistant to immune checkpoint
inhibitors (ICIs), posing a significant clinical challenge that necessitates understanding the mechanisms behind
this resistance. Immunosuppressive myeloid cells have been recognized in tumors, but their heterogeneity has
made CSF1R inhibitors and other broad targeting approaches largely ineffective. My recent prostate cancer
studies identified a distinct subset of tumor-associated macrophages, expressing high levels of SPP1 transcripts
(SPP1hi-TAMs) that encode the osteogenic protein osteopontin (OPN). These cells become significantly more
prevalent during disease progression and contribute to resistance to ICIs through adenosine signaling,
particularly within the prostate. Despite bone being the most common site (>70%) of metastases in mCRPC
patients and the poorer immunotherapy responses observed in patients with bone metastases, the role of bone-
associated myeloid cells in resistance is unclear. My preliminary data identify granulocytes with high expression
of CD62L and CXCR2 (CD62LhiCXCR2hi-gran) as key myeloid cells promoting immunosuppression through IL-
1R signaling in culture. I hypothesize that targeting CD62LhiCXCR2hi-gran and their corresponding molecular
signals could enhance the efficacy of ICIs in mCRPC patients with bone metastases. I now propose to utilize
intraosseous CRPC mouse models to determine whether CD62LhiCXCR2hi-gran are critical for immunotherapy
resistance in vivo. By employing adaptive transfer experiments and pharmacologic interventions in mice and in
situ hybridization imaging of patient bone biopsies, I expect to determine if these granulocytes mediate resistance
to ICIs via the IL-1R pathway, consistent with our initial findings. Moreover, I aim to investigate whether this
suppression mechanism is associated with spatial changes during disease progression by performing 10x
Genomics Xenium in situ spatial transcriptomics analysis on formalin-fixed paraffin-embedded of patient and
mouse tissues. I also plan to determine whether prostate-prevalent SPP1hi-TAMs can modulate the bone-
associated myeloid landscape through long-range communication, particularly with OPN, during the progression
of prostate cancer, and whether inhibiting these interactions can enhance the efficacy of ICIs for treating prostate
cancer in bone. Preliminary results indicate that CD62LhiCXCR2hi-gran not only increase in abundance but also
undergo transcriptional reprogramming during disease progression, with various soluble factors, including CCL5,
being the most abundant drivers of myelopoiesis derived from CRPC cells. I now plan to determine whether
signaling through these factors, particularly the CCR5-CCL5 axis, is necessary and/or sufficient for pathogenic
myelopoiesis in mCRPC bone metastases, and whether it could serve as an immunotherapeutic target. Through
these studies, my goal is to identify novel cellular and molecular therapeutic targets for mCRPC bone metastases,
with the potential to translate into more effective immunotherapies.

Public health relevance
PROJECT NARRATIVE Prostate cancer is the most common male malignancy, with bone being the predominant site (>70%) of metastases in patients with advanced prostate cancer. Patients with bone metastases tend to have poorer responses to immunotherapy compared to those without bone involvement, suggesting the presence of an immunosuppressive niche within bone. To discover molecular targets for improving immunotherapeutic strategies, we will focus on identifying the specific cells and corresponding signals that contribute to immunotherapy resistance in the tumor microenvironment.